Project 2: Exposure to Air Pollutants and Risk of Birth Defects

"Exposures to Air Pollutants and Risk Of Birth Defects" - Birth defects are the leading cause of infant mortality in the US. Our proposed Formative Center's research efforts, will enhance scientific understanding of the potential environmental etiologies of birth defects, which will undoubtedly have important implications for risk assessment and prevention of these common, costly, and often deadly outcomes of pregnancy. In this project (Project 2) we propose to conduct a rigorous population-based epidemiologic study that targets 30 different birth defects. Our research aim specifically proposes to determine whether exposures to specific air pollutants and mixtures of air pollutants, during critical periods of fetal organogenesis, are associated with women delivering infants/fetuses with structural birth defects. In this project we will use data from the largest case-control study conducted to date in the US on birth defects - the National Birth Defects Prevention Study. We will limit our inquiries to the California study site which is being conducted in the San Joaquin Valley - an area with demonstrated poor air quality. To these data, we will provide a much more detailed and specific test of our hypothesis with refined exposure data pertaining to high anibient air pollution. The etiologies of most structural birth defects are unknown. There have been a few observations that point toward ambient air pollutants as risk factors for human birth defects. However, this important public health hypothesis has been under studied owing to the lack of good exposure and outcome data. Thus, Project 2 uniquely fills an important gap in our understanding pf the role of environmental exposure on the risk of human birth defects.

Public health relevance
Birth defects are a global problem that affect -6% of births worldwide. In the U.S. birth defects are the leading cause of pediatric hospitalizations, medical expenditures, and death in this first year of life. Globally, at least 3.3 million children <5 years die each year because of a birth defect. Indeed, birth defects are one of, if not the leading healthcare concern for the youngest members of society.